Mummichog 3, aligning mass spectrometry data to biological networks - Neutral Loss

PROJECT SUMMARY / ABSTRACT The mummichog software was initially published in 2013, as a computational approach to match patterns in metabolomics data to known biochemical networks, without the requirement of upfront metabolite identification. This approach enables rapid generation of biological hypotheses from untargeted data, and has gained considerable popularity, which also creates urgent needs to upgrade the software itself. This proposal aims to add a rich user interface, and better support of LC-MS, LCMS/ MS, IMS/MS and GC-MS. Furthermore, this work will make a conceptual leap to establish a framework of network alignment as a vehicle to interpret metabolomics data by integrating multiple layers of information. The new development will be integrated into XCMS Online and MetaboAnalyst, and will be made freely available as modular software tools.

Public health relevance
PROJECT NARRATIVE The proposed “MS2 to Neutral Loss Spectra Converter and Viewer” comes on the heels of the creation of the new METLIN-Neutral Loss database derived from the METLIN 850K tandem mass spectrometry database. Similarity analysis using tandem mass spectrometry (MS2) data have become valuable approaches for identifying previously uncharacterized molecules (unknowns). Yet key structural information can be lost when relying solely on this fragment ion data, mass spectrometry-based neutral loss (NL) analysis is key to facilitating unknown characterization thus its further development.